Genomics & Epigenomics Shared Resource

GENOMICS & EPIGENOMICS SHARED RESOURCE: PROJECT SUMMARY
“Omics” technologies emerged relatively recently and evolved rapidly, becoming essential to almost every aspect of cancer research. In view of this, the Genomics & Epigenomics Shared Resource (GESR) is an indispensable Shared Resource for the Georgetown Lombardi Comprehensive Cancer Center (LCCC) and serves Center Members on both the DC and NJ campuses. The objective of the GESR is to provide investigators with state-of-the-art services for genomic and epigenomic studies, such as DNA/RNA quality assessment, mRNA expression profiling, miRNA expression profiling, DNA sequencing, single-nucleotide polymorphism (SNP) genotyping, copy number variation (CNV) analysis, DNA methylation analysis and label-free molecular interaction analysis. The GESR uses a variety of platforms for these services, including bioanalyzer, microarray, next-generation sequencing (NGS), real-time–polymerase chain reaction (RT-PCR), count-based expression analysis (NanoString), and surface plasmon resonance (SPR). To facilitate these services, the GESR organizes education and training on emerging technologies and provides bioinformatics support and access to software tools and several user-operated instruments. GESR is co-directed by Habtom Ressom, PhD, Aykut Üren, MD, and Benjamin Tycko, MD, PhD. The GESR also relies heavily on the input from the GESR Advisory Committee (AC) and user surveys to prioritize development and assess programmatic needs across the consortium. To this end, new services such as single-cell RNA-seq, digital spatial profiling, and targeted methyl-seq have been launched since the last submission. In FY2022, the GESR provided services to 33 LCCC Members across all three Research Programs (19 Cancer Cell Biology Members, 11 Cancer Host Interactions Members, and 3 Cancer Prevention and Control Members). During the current project period, the GESR supported basic science and translation research with 37 publications, including 12 manuscripts published in high-impact (IF > 10) journals such as Oncogene, Cell Death Differ, Dev Cell, Clin Cancer Res, and Gastroenterology, and provided critical support that enabled the success of 53 extramurally-funded research project grants, and 4 clinical trials. In summary, state-of-the-art instruments housed in the GESR and high-quality services offered by the GESR contribute to numerous, high-impact collaborative research projects among LCCC Members.